SUBSTRATE ANALOGUES OF MYO INOSITOL 1 PHOSPHATE SYNTHASE

This project is concerned with the design, synthesis and enzymology associated with inhibition of the enzyme myo-inositol 1-phosphate synthase. A series of substrate analogues, reactive intermediate analogues, and one intermediate are synthesized and tested for in vitro inhibition. Mass spectrometry is required to establish structural assignments of synthetic intermediate and water soluble products. The products of MIP synthase-catalyzed reactions have also been analyzed by FAB-MS when other methods were not suitable.